A next-generation morbid map of the human genome

PROJECT SUMMARY/ABSTRACT
The impact of next-generation sequencing (NGS) on gene discovery and molecular diagnostics for Mendelian
conditions (MCs) is hard to overstate. However, to provide affected individuals with precise natural history,
recurrence risk, and prognosis in clinical settings, identification of pathogenic variant(s)/genotypes alone is often
insufficient. This is a challenge most notably for genes that cause more than one MC or ~25% of all genes that
underlie MCs. In such an instance, even with a known genotype a patient's phenotype has to be compared to
that of all MCs caused by variants in a gene to determine which MC, if any, is the likely diagnosis or whether
patient instead has a novel condition. This comparison is increasingly difficult because delineation of the ~5,100
MCs currently known has typically been based on subjective grouping of affected individuals by phenotypic
similarity. We propose to develop a quantitative framework for assessing overlap among the distributions of
phenotypes due to pathogenic genotypes the same gene and apply this framework genome-wide. NGS has
enabled identification of causal genotypes in hundreds of thousands of individuals with MCs, providing a
sufficiently large dataset that it is now feasible to use machine learning to quantitatively and systematically
identify “clusters” of co-occurring genotypes and phenotypic features for each known gene. We will refine and
validate our approach by comparing differences between conventionally-delineated and quantitatively-delineated
MCs and by assessing the similarity of individuals with well-studied atypical phenotypes/genotypes to
quantitatively-delineated MCs. We will then apply the optimal strategy across the genome to generate a “next-
generation morbid map” based on quantitatively-delineated MCs. We will also apply machine learning
approaches to identify genomic properties associated with the propensity for each gene to underlie multiple MCs
(i.e., the numeric contribution of each gene to the morbid map or phenotropy). This will enable a more precise
and complete understanding of the genotypic and phenotypic spectrum of each MC, enable more objective
diagnosis of individuals with atypical phenotypes, and more robustly identify the existence of multiple MCs
among individuals with non-specific “class” phenotypes (e.g., developmental delay, autism, hearing impairment).
We will make all newly developed methods publicly available via interactive and programmatic web-based tools
to facilitate extension of this work to other human and model organism datasets.

Public health relevance
PROJECT NARRATIVE The major goals of this project are to develop a quantitative framework that enables objective delineation of Mendelian conditions, apply the framework to systematically delineate conditions across all genes known to underlie a Mendelian condition, and predict the number of conditions due to each gene. This framework will provide a fuller, unbiased characterization of the genotypic/phenotypic spectrum for all Mendelian conditions, enable more precise diagnoses and counseling of individuals with difficult to diagnose phenotypes, and accelerate the detection of new Mendelian conditions.